Community Health Worker Led Hypertension Prevention and Control (CHPC) in Nepal: An Implementation Trial

ABSTRACT
In Nepal, the prevalence of HTN among adults is 25% is similar to the global prevalence. In Nepal, however, a
comparatively larger proportion of adults (44%) are unaware of their HTN status, 33% of HTN patients are
receiving treatment, and only 12% of the patients have their BP under control. Despite the availability of proven
effective lifestyle changes and low-cost anti-HTN treatment in preventing major vascular events and total
mortality, these recommendations have not been translated into practice. In Nepal, the Package of Essential
Non Communicable Diseases (PEN) was adopted that
includes
protocols to detect and manage HTN at the
basic health facilities However, major implementation barriers at multiple levels exists: (a) Individual level: low
perceived susceptibility, low health literacy, misconceptions; (b) Interpersonal level: peer pressure; (c)
Community level: norms supporting unhealthy eating and low medication adherence; and (d) Organizational
level: unfilled human resource positions, overburdened health staff, interrupted medical supplies and
medicines; inefficient recording and reporting, and inadequate provider-patient interaction. In response to these
multi-level implementation barriers, we propose to implement and evaluate a new task-shifting strategy to
community health workers (CHW), leading to improved HTN prevention and control. CHWs will : (a) engage
with and educate clients more frequently, for longer periods, and in their homes, hence building clients' self-
efficacy; (b) improve health system efficiency by providing quality provider-client time to modify lifestyle,
monitor blood pressure; and (c) CHWs will directly connect the HTN patients with health care providers at
health facilities through time referral. We will conduct a type III hybrid effectiveness-implementation study to
implement and evaluate a CHW led HTN prevention and control (CHPC) implementation strategy to deliver
increased uptake and sustainment of healthy diet, physical activity, and antihypertensive medication use;
leading to lowering of blood pressure.Aim 1 will assessimplementation outcomes of CHPC implementation
strategy using the RE-AIM framework at the patient, provider and health system levels. We will utilize mixed
methods to measure the Reach, Effectiveness, Adoption, Implementation and Maintenance outcomes for
sustained implementation of CHPC. Aim 2 will assess the effectiveness of the CHPC implementation strategy
compared to facility-based PEN on systolic BP via a cluster randomized controlled trial. We will recruit 2432
participants with high blood pressure in 171 geographic clusters randomized to assess CHPC on systolic BP
(primary outcome). Aim 3 will evaluate the economic sustainability of CHPC. We will collect primary cost data
from facilities and participants and use the effectiveness estimate from aim 2 to model the costs and cost-
effectiveness and household out of pocket expenditure impacts. If successful, this study will provide the
governments of Nepal and other LMICs a HTN prevention and control strategy to mitigate the burden of HTN in
low resource settings.

Public health relevance
NARRATIVE Reduction of blood pressure to optimal levels is a major public health priority. Lifestyle modifications, blood pressure monitoring and anti-hypertensive medication have proven to reduce blood pressure. We will conduct a hybrid study to assess the implementation and effectiveness of a community health worker led hypertension prevention and control.